Equipment Supplement for R35 GM144059 "Writers and Erasers of Ubiquitin Moieties in Control of Cell-to-Cell Transport in Plants"

PROJECT SUMMARY
Intercellular transport is central to the life cycle of multicellular organisms, and its
molecular mechanisms and their regulation have been extensively studied in different model
systems, including plants and animals. Yet, one key aspect of cell-to-cell transport regulation
apparently escaped attention: the potential involvement of ubiquitylation/deubiquitylation (and
the corresponding ubiquitin ligases and deubiquitinases). In our parental project, we have
obtained evidence for the existence of such a regulatory system and are characterizing its
molecular components and mechanism(s) of action.
This work heavily depends on the use of a confocal laser scanning microscope to detect
and follow the fate of fluorescently tagged proteins in plant tissues. Based on the current and
projected trajectory of the project, there is an urgent need for improvement of our confocal
imaging quality, i.e., resolution and signal-to-noise ratio, to enhance the quality of acquired data
and their interpretation. To address this critical technical aspect of the project, we propose
acquiring a Zeiss Airyscan 2 detection system with a Zeiss 60A R2 offline analysis workstation
that can be incorporated into our existing Zeiss LSM 900 machine and provide significant
improvement to its imaging and image analysis capabilities.

Public health relevance
NARRATIVE The parental project heavily depends on the use of a confocal laser scanning microscope to detect and follow the fate of fluorescently tagged proteins in plant cells and tissues. Based on the current and projected trajectory of the project, there is an urgent need for improvement of the quality of our confocal image acquisition, i.e., resolution and signal-to-noise ratio, and its analysis. To address this critical technical aspect of the project, we propose acquiring a Zeiss Airyscan 2 detection system with a Zeiss 60A R2 offline analysis workstation that can be incorporated into our existing Zeiss LSM 900 system and qualitatively improve our imaging and image analysis capabilities and substantially enhance the quality of acquired data and their interpretation.